Steering the next generation of NCI-sponsored clinical trials in gastroesophageal cancers

Gastrointestinal cancers, and gastroesophageal adenocarcinomas in particular, are
experiencing a clinical renaissance with the approval of recent biomarker-directed
therapies. With the clinical advances comes multiple new questions for the field, many
of which the NCI-sponsored clinical trials infrastructure is optimally suited to address.
As a leader in the NRG non-colorectal committee and recently elected chair of the NCI
Esophagogastric Task Force I am optimally suited, and deeply committed to leveraging
NCI-sponsored clinical trials to address open clinical and scientific questions in
gastroesophageal cancers. I have demonstrated an altruistic dedication to clinical
research and ability to evaluate and implement NCI-trials at my institution where I am PI
and lead accruer to NRG-GI006 and NRG-GI007. I have multiple relevant institutional
roles including program leadership, IRB core membership and broader satellite network
liaison where I lead efforts to extend NCI-sponsored trials to our community sites to
bring trials to patients where they live. A key feature of successful trial implementation
and accrual is appropriate trial selection informed by patient demographics and
appropriate feasibility. With the support of the R50 Research Specialist award I will
expand a novel trial evaluation program to improve implementation of NCI-sponsored
trials at my institution. Through my roles in the NRG and NCI I will pilot this same
program in evaluating developing concepts at the national level. My ultimate goal is to
develop and implement pragmatic trials that address key questions in the field of
gastroesophageal cancers.

Public health relevance
People and parity are among the central tenets of public health efforts, and improving the design and implementation of NCI-sponsored clinical trials can directly improve patient access and survival. The work proposed in this R50 submission seeks to enhance the matching of NCI-sponsored trials and optimize resource allocation both locally and nationally, which will improve accrual and expedite successful trial completion. Increasing the speed at which we answer clinical questions in NCI- sponsored trials has direct impacts on enhancing health and lengthening life in gastrointestinal cancers.